Comprehensive Cancer Center Support Grant

PROJECT SUMMARY
The primary purpose of the NCI Early Career Investigator Award (ECIA) is to support clinical investigators in
the pursuit of a career in academic clinical trials and grow participation in NCI-sponsored trials at designated
NCI cancer centers. The O’Neal Comprehensive Cancer center at the University of Alabama at Birmingham is
the premier cancer center in Alabama and the surrounding regions. The proposed ECIA application is
specifically designed to provide salary support for dedicated protected time to Dr. Charles Peyton, a urologic
oncologist at UAB. As such, the protected time will be utilized with the following objectives to improve upon the
genitourinary (GU) cancer service line at UAB. (1) Accelerate the growth of GU clinical trial portfolio,
development and accrual at UAB, emphasizing NCI-sponsored clinical trials. Methods will include research
infrastructure development, implementation design and expansion of clinical trial awareness institutionally and
regionally. (2) Increase cross departmental and multi-institutional collaborative engagements with UAB through
NCI designated avenues and clinical trial opportunities. Methods include scheduled collaborative meetings and
attendance of NCI designated collaborative networking and task force groups. Line item, achievable goals will
be designed, executed and audited. (3) Elevate the ECIA recipient as an institutional clinical trial leader.
Methods will provide Dr. Peyton with time dedicated to participating in institutional clinical trial leadership.
Achieving these strategic objectives will elevate the UAB GU cancer service line to a collaborative,
multifaceted leading clinical trial group, providing cutting-edge clinical trials to Alabama and the Southeast
United States.

Public health relevance
PROJECT NARRATIVE The NCI Early Career Investigator Award (ECIA) will be used to facilitate designing and implementing a robust clinical trials program for genitourinary cancer patients at the O’Neal Comprehensive Cancer Center at the University of Alabama at Birmingham. As Alabama’s only National Cancer Institute designated comprehensive cancer center, this program will continue to build upon our success to provide additional cutting-edge therapies and innovations through clinical trial engagement for the people of Alabama and Southeast United States.